Feasibility of MBSR-VR to Reduce Stress among Emerging Adults with T1D

Project Summary/Abstract
The goal of this research is to assess the feasibility of a highly scalable intervention, Mind-fulness-Based Stress
Reduction (MBSR) delivered virtually enhanced with virtual reality (VR), for improving health outcomes through
the reduction of stress in a high-risk population, emerging adults (EAs; 16-20 years) with high levels of stress
reactivity. The primary aim of this project is to adapt MBSR for virtual delivery enhanced with VR in collaboration
with a Youth Community Advisory Board (YCAB, composed of five EAs with T1D) and to assess feasibility and
the acceptability of MBSR-VR for EAs with T1D and elevated levels of stress reactivity. This feasibility study will
use a multi-center randomized controlled pilot study design with 48 EAs with T1D and elevated stress (as as-
sessed with the Perceived Stress Reactivity Scale). EAs will be randomized in a 1:1 ratio to MBSR-VR or treat-
ment as usual (TAU, standard care control). Three cohorts of 16 participants, 48 total, will be enrolled through
two clinical research centers (CRCs) at Wayne State University (WSU) in Detroit, Michigan and Johns Hopkins
University (JHU) in Baltimore, Maryland. The WSU site will recruit via the T1D Exchange (T1DX) and JHU via
their affiliate diabetes clinics. Participants will enter the study during an 8-week period during which research
staff will obtain informed consent and assess eligibility via a stress screener; eligible participants will continue
with their baseline data collection (T1). Once 16 participants have enrolled, they will be randomized in a single
block, 8 to MBSR and 8 to TAU, and those assigned to MBSR will be oriented to the VR technology. All partici-
pants will continue to receive standard medical care from their usual diabetes care provider. Treatment groups
will run for 9 weeks followed by a 4-week post-treatment data collection (T2) period. The YCAB will assist with
monitoring study progress and refining study procedures (e.g., recruitment strategies) over the course of the trial.
Feasibility and acceptability will be established through achieving recruitment, retention and intervention bench-
marks. Recruitment feasibility will be established by accruing 8 participants every 4 weeks (16 over 8 weeks)
and fewer than 15% excluded due to lack of access to an internet-enabled device. Retention feasibility will be
established with 85% retention at the end of treatment data collection and <15% of dropouts due to technology
challenges that impeded study participation. Intervention feasibility will be established if EAs attend ≥5 of 9 MSBR
intervention sessions, ≥90% of the intervention content is delivered, staff collect >75% of self-practice diaries,
MBSR fidelity ratings are ≥4 out of 5 on average, and EAs express satisfaction via qualitative interviews and
quantitative assessment (≥3 out of 4).

Public health relevance
Project Narrative The goal of this research is to assess the feasibility and acceptability of virtually delivered Mindfulness-Based Stress Reduction enhanced with virtual reality (MBSR-VR) to improve health outcomes through improved stress coping in a high-risk population: emerging adults (EAs; 16-20 years) with type 1 diabetes and high levels of stress reactivity. If successful, virtual MBSR is a scalable intervention with the potential for broad reach to a high-risk population, EAs with a chronic illness and high levels of stress, a group empirically linked to poor health out- comes. This research will also explore any effects MBSR has on glycemic control, psychological distress (stress, depression, and anxiety), and mindfulness.